EFFECT OF INSULIN CONCENTRATIONS AND FASTING PULSATILE GROWTH HORMONE SECRETION

Compare pulsatile GH secretion in fasted subjects during euglycemic hyper-insulinemic clamp experiments and saline infusions.